TISSUE SPECIFIC EXPRESSION OF CYTOCHROME C OXIDASE

The goals of this project are to determine the genome organization and genetic regulatory sequences controlling expression of nuclear genes for cytochromoe c oxidase subunits in humans. Mammalian cytochrome oxidase consist of at least twelve subunits, which are the products of two separate genomes. The three largest polypeptides (I-III) are mitochondrial gene products, whereas the smaller polypeptides (IV-VIII) are nuclear gene products. Futhermore, many of the nuclear encoded oxidase subunits have tissue-specific forms, implying the existence of more than one expressed gene for these subunits. The specific aims are to determine the pattern of tissue-specific expression and the genome organization of subunit IV genes. These goals will be accomplished by isolating and sequencing cDNAs for skeletal muscle and fetal heart libraries and comparing these sequences with that of human liver cDNA. The pattern of expression of subunit IV genes in liver, heart, muscle and kidney will be determined by analyzing transcripts by Northern blot analysis, S1-nuclease mapping and primer extension experiments. The genome organization will be determined by characterizing and sequencing genomic clones. Regulatory sequences will be analyzed by means of gene fusions with the CAT gene. These fusions will be introduced into several different human and rodent gene(s) will be mapped to human chromosomes by means of somatic celll hybrids and human DNA will be analyzed for restriction fragment length polymerphisms. Finally, cDNA probes for other oxidase subunits will be isolated by constructing and screening a beef heart expression library with antibody to beef heart oxidase and with synthetic oligonucleotide probes. These studies are crucial to our understanding of regulatory signals involved in controlling expression of this essential enzyme complex and in understanding the genetic basis of inherited cytochrome oxidase deficiencies.